DIET RESPONSIVENESS TO SATURATED FAT AND CHOLESTEROL IN HEALTHY YOUNG ADULTS

Individuals differ in the response of their LDL-C levels to dietary cholesterol and saturated fat. It has been suggested that variation in cholesterol absorption may explain some of these differences. We intend to study individuals on low fat-low cholesterol, high fat-high-cholesterol and high fat-low cholesterol diets. This will allow us to determine under highly controlled metabolic ward conditions whether cholesterol absorption is a determinant of LDL-C levels and diet response.